DESIGN OF INFLUENZA VIRUS NEURAMINIDASE INHIBITORS

DESCRIPTION: (Adapted from the abstract). The proposed studies will continue efforts to design novel inhibitors of influenza virus replication guided by the structure of the active site of the viral NA as determined from its crystal structure. Benzoic acid derivatives, which are chemically stable and simple to synthesize, have been found to be inhibitory with the most effective compound having an IC-50 of about 10 micromolar. The applicants now plan to further optimize the structure of the benzoic acid derivatives in the hope that they will produce an inhibitor which is active in the nanomolar range. Computer- aided design procedures carried out by the applicants have identified a new pocket in the active site of NA. They plan to utilize this new information and to design a new series of compounds which reach to that site in their effort to further reduce the Ki of their inhibitor. The third approach will be to use what they have learned about the NA binding site to work out the chemistry for the synthesis of alternative compounds. The third aim is proposed as a back up in the event that the pharmacological properties of the benzene derivatives prove to be problematic.